Urine based circulating tumor DNA analysis

ABSTRACT
Urine is an underappreciated source for systemic circulating tumor DNA in patients with non-genitourinary
cancers. Based on recent data suggesting that blood-based HPV DNA testing is useful for disease monitoring
in HPV positive oropharynx cancer patients, we identified non-metastatic HPV positive oropharyngeal cancer
patients as an excellent model system to examine the potential of urine-based transrenal DNA analysis. Our
preliminary data suggests that our newly developed urine-based HPV test could have biomarker performances
comparing favorably to blood-based HPV testing.
The specific objectives of this application are to establish that urine is a suitable source for HPV DNA in non-
metastatic HPV positive oropharynx cancer patients, and that at-home urine based molecular testing is feasible
for these patients. Specifically, we will compare sensitivity and specificity of pre-therapy urine-based HPV
testing to tissue gold standard testing in a cohort of newly diagnosed non-metastatic oropharyngeal cancer
patients. Recurrence detection lead time of urine-based HPV testing will be compared to clinical routine care in
the same cohort after curative intent treatment. Controls will include blood-based HPV testing, pharyngeal
swab-based HPV testing and blood based personalized ctDNA sequencing panel testing. Additional control
cohorts will include cervical and anal cancer patients as well as cancer-free patients with recently diagnosed
oncogenic HPV infections. Using in vivo fluorescence imaging techniques, we will generate fundamental
knowledge on renal handling of cell free DNA and determine the impact of chronic kidney disease and other
patient, disease and iatrogenic factors on cell free DNA excretion.

Public health relevance
NARRATIVE We developed a novel urine-based HPV test, with test performances comparing favorably to blood-based HPV testing. Using this test, we obtained preliminary data suggesting first details of the physiological processes underlying blood cell free DNA excretion into urine. This proposal will expand on these findings and explore the potential of our test as a biomarker in oropharyngeal cancer patients undergoing curative intent radiation therapy.